CLARITHROMYCIN AND ETHAMBUTOL WITH OR WITHOUT CLOFAZIMINE TO TREAT DMAC IN HIV

The primary purpose of this study is to assess the tolerance of the combination of clarithromycin plus ethambutol with or without clofazimine in the treatment of disseminated Mycobacterium avium disease. A secondary objective is to determine the proportion of patients of patients achieving a sterile blood culture, the time required to achieve a sterile culture, and the length of time the culture remains sterile.